Virtual Reality Intervention for Stress, Resilience, and Blood Pressure Management in Black Women

REALIST WOMEN Study
A Virtual Reality (VR) Interven�on for Stress, Resilience, and Blood Pressure Management in Black Women
Background: Black women have a higher rate (approximately 60%) of cardiovascular disease (CVD) risk markers (e.g.,
hypertension) compared to their white female counterparts aged 20 and older (45.4%). Addi�onally, Black women are
more likely to suﬀer from insuﬃcient sleep (less than 6 hours), increasing their CVD risks. Stressors, especially complex
and cumula�ve intersec�onal stressors (such as economic strain, caregiver burden, racial stress, and gender
discrimina�on) experienced by Black women, are upstream determinants of hypertension and insuﬃcient sleep. To cope
with intersec�onal stress, Black women have developed unique forms of resilience. Current psychological and mental
health treatments do not speciﬁcally address intersec�onal stress. Therefore, to address the intersec�onal distress
experienced by Black women, we need behavioral treatments that can provide therapeu�c relief when needed. Innova�on
and Approach: Realist Women Study aims to pilot test the eﬀec�veness of a culturally tailored VR-exposure stress
management program in addressing intersec�onal stress and improving cardiovascular health in Black women. This K01
study aims to conduct focus group and individual interviews with 16 Black women to develop a community-deﬁned
concept of resilience. Addi�onally, the study will assess stress, sleep health, and feedback on using virtual reality (VR) for
stress management. It will also explore barriers and mi�ga�on strategies related to immersive technology usage among
Black women dealing with the superwoman schema coping (SSC). The Study is a pilot randomized clinical trial with (RCT)
a total of 60 par�cipants, focusing on hypertensive Black women. The hypothesis is that par�cipants in the stress
management virtual reality (VR-SM) group (n=30) will experience reduced stress (a minimum 12-point reduc�on in
cumula�ve intersec�onal stress scores), an increase of at least 0.77 points in CD-RISC scores, more days of suﬃcient sleep
(at least 7), a signiﬁcant decrease in blood pressure (BP), and adherence to the VR-SM program (using at least 50% of the
total modules). This research seeks to address a cri�cal gap in the literature by exploring the feasibility and impact of VR-
based interven�ons in this underserved popula�on. Relevance: The Study aims to reduce morbidity and mortality
associated with hypertension and insuﬃcient sleep in Black women by providing an innova�ve and accessible VR-based
interven�on tailored to their unique needs. This research represents a crucial step in addressing health dispari�es and
improving cardiovascular outcomes in this high-risk demographic. This K01 award will provide pilot data for an R01-level
RCT to develop a VR-delivered, culturally tailored Mindfulness-Based Stress Reduc�on (MBSR) program to enhance
resilience to cumula�ve intersec�onal stress and BP management for Black women. It will also further the candidate’s
training in psychological trauma research and biobehavioral medicine, equipping her with new skills in prac�ce-based
clinical trials, digital health interven�ons, ac�graphy, ecological momentary assessments, and advanced research design
and analysis. These skills will ensure her success as an independent inves�gator focused on inves�ga�ng and addressing
unique stress responses among minori�zed popula�ons while examining the eﬀects and mechanisms of scalable digital
health solu�ons for Black women experiencing elevated stress levels, poor sleep, cardiovascular health issues, and
psychological resilience.

Public health relevance
REALIST WOMEN STUDY The research project aims to address the higher cardiovascular disease (CVD) risk markers in Black women, inﬂuenced by factors such as insuﬃcient sleep and cumula�ve intersec�onal stress. To tackle this, the project proposes u�lizing innova�ve and accessible virtual reality (VR) technology for stress reduc�on and resilience s�mula�on, with a speciﬁc focus on Black women in South Florida. The ul�mate goal is to provide training in culturally tailored interven�ons for the researcher to address the unique stress-related health challenges faced by Black women, including cardiovascular issues, poor sleep, and psychological resilience.